Integrative Data Analysis of Psychosocial Treatment Studies for Adolescent ADHD

Project Summary. During the last six years, our team conducted four randomized clinical trials of psychosocial treatments for adolescents with ADHD with a cumulative sample size of 876 youth (ages of 11- 17; Sibley et al., 2016, under review, in preparation, in progress) with funding from the NIMH (R34 MH092466, R01 MH106587), Institute of Education Sciences (R305A150433), and the Klingenstein Third Generation Foundation. In the current proposal, we outline a plan to conduct an Integrative Data Analysis (IDA; Curran & Hussong, 2009) that will pursue a linked series of person-level treatment outcome analyses. We will combine multimethod (i.e., observational, parent-rated, self-rated, teacher-rated, official records) data from the four recent RCTs (cumulative N=876) that evaluate brief psychosocial treatments for adolescents with ADHD across a range of settings, interventions, and referral characteristics. Common across studies is a Baseline (BL)-Post Treatment (POST)-Follow up (FU) design and a standard battery was delivered across studies that includes core primary and secondary outcome measures (see Table 3). In the first months of Y01, Drs. Sibley & Coxe will work with Dr. Curran to create a harmonized data set. Following completion of the final database, the team will conduct a series of Latent Class Analyses, Mixture Models, and Structural Equation Models as outlined in the study aims. These analyses will identify treatment-related phenotypes and family-risk profiles using latent class analysis that organize the heterogeneous population into clinically meaningful subgroups. We will then examine questions of treatment moderation, such as whether latent classes predict treatment engagement (% of prescribed treatment course attended), and whether latent classes and adjunctive supports (i.e., medication, parent involvement style, school accommodations) predict treatment response trajectories on two primary outcomes (parent-rated ADHD symptoms and GPA). We will also examine whether there are treatment-level variables (time of year, setting of treatment, content of treatment) that moderate the relationship between phenotype and response. Finally, we will use structural equation modeling to identify key treatment mediators (i.e., teen organization skills, parent contingency management, parent-teen conflict, parental well-being) and to examine whether significance of mediators varies by phenotype, treatment-level variables, and parenting profile. We believe that pursuing personalized medicine questions for adolescents with ADHD could provide useful information that promotes improved treatment engagement and response? leading to meaningful changes in long-term outcome for individuals with ADHD, whose adult trajectory is highly related to experiences in adolescence (Barkley et al., 2008; Molina et al., 2012; Sibley et al., 2014). Treatment research for adolescents with ADHD lags behind research on treatments for children with ADHD. As a result, complex person-level and mediator x moderator analyses have not been conducted with this population? namely due to sample size limitations in extant studies.

Public health relevance
Project Narrative It is believed that adolescence is a critical period for ADHD intervention to change the trajectory of illness given the close relationship between functioning in adolescence and the persistence of ADHD into adulthood (Barkley et al., 2008; Molina et al., 2013; Sibley et al., 2014). Yet within the field of adolescent ADHD, almost nothing is known about which treatments work best for whom, when, where, and how; practitioners have very few guidelines for treatment selection and tailoring—critical choices that influence a treatment’s initial credibility and consequent patient retention in care (Gray, 2013). To guide these recommendations, this study will represent a first attempt to pursue complex moderator x mediator and person-level analyses in a large sample of adolescents with ADHD enrolled in an RCT of psychosocial treatment.